Preclinical Efficacy and Intermediate Endpoint Biomarkers - Orientation Meeting

University of Oklahoma Health Sciences Center has been awarded as a prime contractor of RFP-N01-CN25002-78 entitled “Preclinical Efficacy and Intermediate Endpoint Biomarkers.” They are scheduled to attend the orientation meeting that is scheduled on Oct. 22.